Enzyme Chemistry and Biological Function of RiPP-like Modifications

Our group seeks to identify new molecular structures formed by unusual enzymatic transformations. We focus
on the ribosomally synthesized and post-translationally modified peptides (RiPPs), of which nearly 50 distinct
structural classes exist. Decades of research show that while RiPPs harbor diverse structures and functions,
the biosynthetic routes share a blueprint. Typical RiPP precursor peptides contain fewer than 60 amino acids.
The modification enzymes engage the N-terminal portion, while the C-terminal region receives all post-trans-
lational modifications (PTMs). Genome mining for RiPP biosynthetic gene clusters (BGCs) had been ex-
tremely time-consuming and often unsuccessful owing to the difficulty of locating the requisite substrate pep-
tide(s). The short length and hypervariability of RiPP precursor peptides frequently preclude their detection
by automated gene finders. RODEO, an AI-based genome mining tool, has largely solved this problem for a
subset of RiPP classes. The current proposal unites RODEO-enabled genomics analysis, enzyme chemistry,
structural biology, and microbial physiology to characterize several “RiPP-like” BGCs that do not conform to
the current definition of a RiPP natural product.
With the breadth and depth of RiPP genomics coming into sharper focus, it has become increasingly clear
that many “RiPP-like” BGCs lack a canonical precursor peptide. Rare PTMs such as backbone thioamidation
and thioether crosslinks between cysteine and the side chains of other amino acids are known on larger
protein substrates, such as methyl-coenzyme M reductase, ribosomal protein uL16, and quinohemoprotein
amine dehydrogenase. These examples establish limited but critical precedent, and we herein predict that
many more “RiPP-like PTMs” occur on protein substrates. Comparative analysis in prokaryotes supports this
prediction, as a substantial level of sequence and genome neighborhood similarity exists between pathways
encoding a canonical precursor peptide versus a larger protein substrate.
This renewal project tackles several questions of outstanding interest regarding the interplay and utility of
RiPP-like PTMs on non-canonical substrates. The specific aims are independently achievable and robustly
combine in silico, in vitro, and in vivo methods. In one aspect, we will elucidate the biochemical function of
ribosome thioamidation and the extent to which this PTM is propagated among other prokaryotes. Additional
thioamidated proteins and their physiological roles will be discovered during this project. Further, we will pur-
sue biosynthetic pathways predicted to produce poly-thioether-stabilized protein nanotubes and poly-isopep-
tide-containing branched copolymers. The enzymes performing this usual PTM chemistry will be thoroughly
evaluated, and the biological roles of the protein ultrastructures will be determined. Our preliminary data, rich
environment, and strong investigative team place us in an ideal position to address these aims that will sig-
nificantly advance the study of RiPP protein chemistry and microbiology.

Public health relevance
Project Narrative: Douglas A. Mitchell, Ph.D. There are only twenty common amino acids used to produce protein. Chemical modification of is one mechanism by which Nature squeezes more functionality out of a limited set of amino acid building blocks. There are well known “post-translational” modifications, but in our field of study, which focuses on microbial natural product biosynthesis, new exotic modifications are being frequently discovered. This project will define the extent to which these new modifications are employed on larger proteins and the functional significance of those modifications.